Administrative Core

Project Summary/Abstract
An efficient administrative structure is essential to the design and implementation of the Developmental
Synaptopathies Consortium (DSC). The overarching goal of the Administrative Core is to create an environment
in which scientific research relevant to the goals of the DSC can be effectively and efficiently designed, conducted
and disseminated. This Core was very successful in establishing an administrative and management structure
for the DSC that has worked proficiently for the past ten years and has formed valuable partnerships with patient
advocacy groups (PAGs) to identify priority areas and raise funding for additional projects and purposes of the
DSC, recruit subjects and disseminate information with respect to the initial three rare disorders: TSC, PHTS
and PMS, and is planning to do the same with the forth added rare disorder, SYNGAP1-ID. The Core will be
staffed by the director, the clinical team liaison, the coordinator/project manager, the core/regulatory manager,
the financial manager, the biostatistician and two bioinformaticians, one with expertise on neuropsychological
assessments, who all are experienced in multi-site clinical research projects. The Administrative Core focuses
on facilitating communication, collaboration, planning, data sharing, and scientiﬁc and ﬁscal oversight of all
research projects for the DSC. The Administrative Core will organize the investigator launch meeting, as it has
done for the past two grant cycles, as well as the Executive Advisory Committee, Steering Committee, Pilot
Feasibility Core, Biomarker Core, Career Enhancement Core, and research study staff and neuropsychologist
meetings at regular intervals. The Administrative Core will be responsible for the following Speciﬁc Aims: 1)
coordinating clinical research projects across all four rare disorders (TSC, PHTS, PMS and SYNGAP1-ID)
leveraging the expertise of the neuropsychology, biomarker and biostatistics teams; 2) developing superior core
processes (Pilot Feasibility Core and Career Enhancement Core) that best meet the needs of investigators,
trainees and the community; 3) serving as a liaison to other organizations, including PAGs, the NIH, DMCC and
the RDCRC Network; 4) disseminating the results of DSC-related research to the patient and investigator
communities; 5) promoting a cohesive and integrated consortium in order to maximize the combined efforts of
our investigators and resources – achieved through detailed communication and operational planning; and 6)
providing outstanding administrative leadership with respect to managing day- to-day operations and maintaining
high-quality, efficient and cost-effective services throughout the DSC.